Prehabilitation of Veterans with Exercise and Nutrition (PREVENT)

Approximately half a million operations are performed each year in VA hospitals across the country.4 Veterans
undergoing high-risk surgery have a 1 in 5 chance of suffering complications, a 1 in 10 chance of being readmitted
to the hospital within 30 days, and a 1 in 50 chance of dying within 30 days.4 Long-term survival is significantly
reduced for those patients who have perioperative complications, even if they survive to leave the hospital.5
Low fitness and poor functional status are among the strongest predictors of postsurgical
complications.1,2 Prehabilitation takes advantage of the weeks leading up to surgery in order to improve fitness,
mobility and nutrition in preparation for the upcoming surgical stress.13 Indeed, prehabilitation has been shown
to improve fitness and reduce complications and quality of life in high-risk surgical patients.7,9,12 The most
effective prehabilitation programs combine exercise plus nutritional support (are multimodal), and provide
exercise that is supervised and individualized, ensuring the appropriate exercise intensity and increasing it
gradually according to improvements in fitness and strength. Most supervised prehabilitation programs are
facility-based, but travel time, distance, and transportation limit participation.10 Unfortunately, home-based
prehabilitation programs have shown small effect sizes and low compliance rates, likely because adequate
training intensity is required in programs of such short duration, which is often not achieved with unsupervised
home-based programs.14-16 [[A prehabilitation program that is delivered using telehealth would be ideal,
because it combines accessibility with supervision, encouraging compliance and ensuring adequate training
intensity, but such programs do not currently exit within the VA]].
[[We aim to determine the feasibility, acceptability, safety, and effect size estimates for outcomes of interest of
a short-term (3-4 week) multimodal prehabilitation intervention that is supervised and individualized, yet is
delivered at home using telehealth technology.]] The exercise program will consist of 3 days of supervised
telehealth exercise sessions per week consisting of moderate intensity aerobic training and resistive and
functional training. Nutritional support will consist of tailored nutritional advice, whey protein
supplementation and multivitamin and vitamin D supplementation during prehabilitation and following
hospital discharge for [[6 weeks]]. Compliance with the interventions will be enhanced by daily automated text
messages using the VA Annie App. In addition, participants will be contacted weekly in order to identify
problems with compliance and to provide counseling. [[Post-operative exercise sessions will resume as early as
1 week postoperatively and progressed as allowed according to the type of surgery. Text messages and weekly
calls will also resume postoperatively until the 6-week follow-up visit to encourage progressive increases in
unsupervised physical activity and nutritional support. Objective physical activity data will be collected using
physical activity trackers, which patients will wear from the time of enrollment until the 6-week postoperative
follow-up visit. Follow-up will continue for a total of 6 months postoperatively.]]
The main outcomes of interest include feasibility (acceptance rates), acceptability (compliance rates), and safety
(number of adverse events). We will also measure changes in fitness, nutritional state, anxiety and depression,
and health-related quality of life throughout the study period in order to estimate effect sizes, which will inform
a future randomized trial. The proposed work combines several innovations in the delivery of exercise and
nutrition and applies them to the perioperative high-risk population for the first time. It constitutes the first step
toward the study of a multimodal “tele-prehabilitation” program on postoperative and long-term outcomes
following high-risk surgery.

Public health relevance
The goal of VA's RR&D office is to maximize functional recovery. This proposal will allow us to test an intervention that combines the fundamentals of Physical Medicine and Rehabilitation with state-of-the-art nutritional support and innovations in care such as telehealth and the use of activity trackers to optimize patients before high-risk surgery. This intervention has the potential to not only reduce complications and hospital readmissions, but also to maximize functional recovery and quality of life for thousands of Veterans undergoing high-risk surgery every year. Furthermore, the proposal is the first step in the design and implementation of prehabilitative services for Veterans living in rural areas and those with inadequate support or transportation.